INTRAVENOUS AZATHIOPRINE TO DECREASE TIME TO RESPOND TO PTS WITH CROHN'S

The purpose of this study is to compare azathioprine IV loading dose with placebo IV loading dose for induction of remission in active Crohn's disease.